Clinical benefits and mechanism of action of angiotensin-II receptor blocker on Cardiovascular remodeling in patients with repaired coarctation of aorta

PROJECT SUMMARY/ABSTRACT
The median survival in adults with repaired coarctation of aorta (COA) is ~55 years, and more that 50% of
deaths are due to end-stage heart failure and sudden cardiac death from left ventricular (LV) systolic/diastolic
dysfunction. LV dysfunction results from chronic pressure overload from hypertension, which in turn leads to
LV remodeling (increased fibrosis and stiffness, and impaired relaxation). LV dysfunction has been observed in
COA patients with borderline hypertension or stage 1 hypertension (B/S1) (blood pressure 120-139/80-89
mmHg), even though the severity of hypertension in these patients is considered significant enough to warrant
antihypertensive therapy based on the current guidelines. Additionally, COA patients with B/S1 hypertension
have impaired aerobic capacity and exhibit hypertensive response to exercise, both of which are associated
with cardiovascular adverse events The pathophysiologic mechanisms responsible for LV remodeling and
abnormal hemodynamic response to exercise in this subset of COA patients are not well understood but are
postulated to be due to increased aortic stiffness. We recently demonstrated that a 2-week course of
angiotensin-II receptor blocker (ARB) improved aortic stiffness, coronary flow reserve (CFR), cardiac output
reserve and vasodilatory reserve (VDR) during exercise. However, it is unknown whether these hemodynamic
changes will lead to LV reserve remodeling (decreased fibrosis and stiffness, and improved relaxation) and
improved aerobic capacity during long-term therapy. Our long-term goal is to prevent early cardiovascular
death in COA patients, by identifying and modifying the pathophysiologic mechanisms leading to LV
dysfunction and vascular complications in this population. Our overall objective for this application is to
determine whether ARB might promote LV reserve remodeling and improve aerobic capacity, and to delineate
the mechanisms of response to ARB. Our central hypothesis is that ARB will promote LV reserve remodeling
and improve aerobic capacity by improving CFR and VDR.
This hypothesis will be tested by pursuing two specific aims: (1) Determine whether ARB promotes LV reverse
remodeling in patients with repaired COA and B/S1 hypertension and delineate the mechanisms of response to
ARB; (2) Determine whether ARB improves aerobic capacity and delineate the mechanisms of response to
ARB. We will randomize 80 subjects 1:1 to ARB (losartan 50 mg) or placebo for 52 weeks. These subjects will
undergo multi-domain assessment of cardiovascular structure and function at baseline and after 52 weeks of
therapy. This proposal is innovative because it will novel magnetic resonance imaging techniques to assess
cardiovascular response to ARB in patients with repaired COA. The results will be significant because it will
enable the development of novel management paradigms for prevention of LV dysfunction and cardiovascular
death in this population.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because delineation of the clinical benefits and mechanism of cardiovascular remodeling in patients with coarctation of aorta receiving angiotensin-II receptor blockers (ARB) will help develop novel management paradigms for prevention of left ventricular dysfunction and cardio- vascular death in this population, which will in turn save lives, reduce morbidity, and reduce healthcare costs. Successful completion of the proposed research in this application will provide strong justification for future multicenter clinical trials to determine the survival benefits of ARB and other classes of antihypertensive medi- cations in patients with repaired COA. The proposed research is relevant to the part of the NIH’s mission per- taining to the pursuit of knowledge to extend healthy life and reduce the burdens of illness and disability.